Laryngotracheal Reconstruction with Engineered Cartilage

PROJECT SUMMARY/ABSTRACT
Severe subglottic stenosis, the narrowing of the airway just below the vocal folds, develops as a response to
intubation in close to 10% of the > 20,000 premature births per year in the United States. Severe cases require
laryngotracheal reconstruction (LTR), in which surgeons split the cricoid and add a piece of autologous patient-
derived cartilage to expand the airway and restore proper airflow. However, in children, the success rate is as
low as 50% with a high incidence of restenosis requiring revision surgery. Graft failure is tied directly to the lack
of sufficiently sized autologous cartilage in the child, and tissue engineering has been proposed to develop
alterative grafting options for pediatric LTR. Some approaches, including some of our previous work, have
been effective in producing functional cartilage, but the overall timeframe required for the construct to match
the mechanical properties of native cartilage (>24 weeks) is not compatible with clinical translation (<8 weeks).
Furthermore, current cell sources such as expanded autologous chondrocytes and mesenchymal stem cells
frequently result in hypertrophic and calcified tissue. Our objective is to engineer a new type of cartilage
implant that is populated with patients’ cells, mechanically viable and suitable for LTR within a clinically
relevant timeframe. Our approach uses a microstructured polymeric scaffold with over 90% porosity and
sufficient mechanical properties and with a pore structure uniquely capable of enhancing chondrogenesis of
stem cells. Furthermore, cartilage progenitor cells have been proposed as a rapidly proliferating, highly
chondrogenic cell source. To harness these cells, we have developed a minimally invasive biopsy procedure to
harvest ear Cartilage Progenitor Cells (eCPCs). Our overarching hypothesis is that the microstructured
polymeric scaffold combined with eCPCs will create cartilage implants with suitable mechanical strength,
dimensions, and phenotypic stability for personalized, minimally invasive LTR. We propose to identify the
microstructure that achieves the maximum chondrogenesis and the specific mechanism of action. The capacity
of eCPCs to produce a robust cartilage phenotype, potentially better than that of ear chondrocytes and less
prone to calcification, will also be studied. Finally, the engineered cartilage derived from the eCPCs seeded in
the microporous scaffold will be test in a porcine LTR model. We expect that our findings will introduce a major
innovation in the treatment of subglottic stenosis, laying the basis for long term pre-clinical safety studies and
clinical translation in airway reconstructive surgery in children.

Public health relevance
NARRATIVE Close to 10% of the over 20,000 premature children every year develop airway disorders that often require laryngotracheal reconstruction using cartilage harvested from the rib cage, but this approach is invasive and cannot be applied to younger children, which motivates an urgent need for new, improved technology. We propose an innovative approach to produce functional cartilage for grafting using an instructive, degradable scaffold that direct the chondrogenic differentiation of a novel autologous cell sources obtained by a minimally invasive biopsy. The in vitro and in vivo proposed studies are aimed at defining new, less invasive and more effective therapeutic options for laryngotracheal reconstruction.